The Pediatric Precision Sleep Network

ABSTRACT

Peri-adolescence (ages 10-13) heralds an alarming escalation in pediatric mental health (MH) risk, making this transitionary time between childhood and adolescence a crucial window for early detection and intervention. Predictive models built on electronic health record (EHR) data are emerging as practical tools to automate MH risk stratification in pediatric primary care (PPC); however, to date these models have only modest predictive value. Common, causal, and modifiable transdiagnostic MH risk factors are needed to improve on EHR models and pave the way for deployment of preventive care during peri-adolescence. Sleep is one such risk factor: more than 50% of peri-adolescents experience unhealthy sleep patterns, and sleep problems during peri-adolescence prospectively predict negative MH outcomes more strongly than at other times in development. However, several barriers have impeded the incorporation of sleep into PPC screening and risk stratification tools: (1) the heterogeneity of sleep characteristics hinders the differentiation of normative versus at-risk sleep patterns; (2) the multidimensionality and multimodality of sleep data have led to inconsistencies regarding which particular features and modalities are needed for screening; and (3) until very recently, it has been impossible to capture crucial behavioral and physiological measures of habitual sleep in sufficiently large samples. To address these challenges, we propose the Pediatric Precision Sleep Network: a multi-site observational study of unprecedented scope and scale, focused on establishing sleep signatures that predict transdiagnostic MH problems among youth in PPC. Across three sites, we will recruit a sample of 1,200 youth (10-13yr) with a range of sleep disturbances from PPC settings. We will develop and validate multidimensional and multimodal sleep signatures (Aim 1) and practical and scalable transdiagnostic MH risk stratification algorithms (Aim 2). Aims 1-2 will employ a sequential, multimodal machine learning workflow to establish the extent to which each data modality can incrementally inform signatures and identify youth at greatest transdiagnostic MH risk. These findings will inform screening, risk stratification, and future developmentally-appropriate effectiveness and/or experimental therapeutics trials. In Aim 3, we will coordinate with the IMPACT-MH Data Coordinating Center to efficiently recruit participants, collect data, hone and share innovative data processing pipelines, and securely transfer data. We are committed to bringing sleep and MH data to our broader scientific community, along with the accompanying tools and resources needed to process sleep data efficiently. Our long-term goal is to inform clinical decision-making algorithms for PPC that leverage sleep to improve MH outcomes at a pivotal developmental window.

Public health relevance
PROJECT NARRATIVE Sleep disturbances in early adolescence are a major source of transdiagnostic mental health risk, including those associated with long-term morbidity and mortality including depression, substance use and suicide. The Pediatric Precision Sleep Network will identify clinically relevant sleep signatures that predispose youth to future mental health risks and develop predictive models that will inform screening and risk stratification based on these clinical signatures in primary care settings.